Allosteric Regulation of Human G Protein-Coupled Receptors by Membrane Lipids

PROJECT SUMMARY/ABSTRACT
The long term goal of our research program is to understand at an atomic level the
mechanisms by which lipids regulate human G protein-coupled receptor (GPCR) activity, and in turn
learn how GPCRs influence their surrounding membrane environment. GPCRs drive many
physiological processes and represent the largest family of “druggable” protein targets. Drug binding
and GPCR signaling are both allosterically regulated by the surrounding cellular environment through
receptor-lipid interactions. Such membrane-protein interactions are ubiquitous within the cell and
have well documented roles in physiology, however, little is known about the structural mechanisms
by which membranes regulate GPCR function. The need to address this gap in knowledge is
heightened by more recent studies associating GPCR-lipid interactions with cell-specific drug
responses and revealing critical roles of GPCR-lipid interactions in a wide range of diseases,
including Alzheimers’ disease, cancers, and heart disease. Our research will capture the different
roles by which lipids regulate GPCR function, both as specific chemical partners and through the bulk
physical and chemical properties of lipids, by integrating unique capabilities of solution and solid state
nuclear magnetic resonance (NMR) with additional biophysical tools and correlative functional
assays. Initial efforts are directed at two lines of investigation aimed at addressing the most
immediate and important questions regarding receptor-lipid interactions. In the first, we will determine
how lipids modulate drug binding and signal transduction for the A2A adenosine receptor (A2AAR), a
representative model GPCR that shares structural and functional characteristics with many
rhodopsin-like receptors. These studies will reveal how lipids impact protein dynamics, alter activation
“hotspots”, and regulate formation of signaling complexes. Integrating this new data with available
pharmacology and crystal structures will provide a new conceptual framework for interpreting cell-
specific drug responses. In the second direction, we will determine the structural mechanisms by
which membrane lipids allosterically modulate signaling of the smoothened receptor (SMO), a
hedgehog signaling protein and validated cancer target. SMO functions in primary cilia, specialized
organelles packed with sensory proteins that act as cellular “antenna”. An emerging concept is that
ciliary membrane composition is fine-tuned for receptor function, yet little is actually known about the
properties of receptor-lipid interactions in ciliary membranes. Our work will reveal for the first time
how both specific lipids and bulk lipid properties regulate SMO signaling complexes. Together, these
lines of investigation will reveal basic principles of lipid-mediated allostery and set the stage for long
term efforts to apply these principles to design drugs targeting specific receptor-lipid interactions.

Public health relevance
PROJECT NARRATIVE On the surfaces of human cells, sensory proteins are activated by not only by molecules outside the cell but also by lipids of the membrane environment in which they function. We seek to understand how the cellular membrane environment affects the activities of these sensory proteins, including affecting their abilities to bind drugs and transmit information inside the cell that ultimately causes physiological responses. The results of this work provide fundamental information into how receptor- lipid interactions in the membrane can be leveraged to design novel inhibitory or activating drug molecules.